SALINE VS HEPARIN IN MAINTENANCE OF NEONATAL PERIPHERAL INTERMITTENT INFUSIONS

There will be no difference in duration of patency of peripheral intermittent infusion devices between saline and heparin flushes in the neonatal population.